Multimodal imaging of brain activity to investigate walking and mobility decline in older adults

Project Description: Mobility impairments in older adults decrease quality of life and are associated with high
societal and economic burden. NIH RFA-AG-18-019 solicits applications “…to investigate the central neural
control of mobility in older adults…using innovative and cutting-edge methods.” Current approaches to study
the neural control of walking are limited by either the inability to measure people during walking (functional
magnetic resonance imaging, fMRI) or the inability to measure activity below the cortex (functional near-
infrared spectroscopy, fNIRS). We assert that a full and accurate understanding of the neural control of walking
in older adults requires real time measurement of active regions throughout the brain during actual walking. We
will achieve this by using innovative mobile brain imaging with high-density electroencephalography (EEG).
This approach relies upon innovative hardware and software to deliver three-dimensional localization of active
cortical and subcortical brain regions with high spatial and temporal resolution during walking. The result is
unprecedented insight into the neural control of walking. Here, our overarching objective is to determine the
central neural control of mobility in older adults by collecting EEG during walking and correlating these findings
with a comprehensive set of diverse mobility outcomes (clinic-based walking, complex walking and community
mobility measures). Our first aim is to evaluate the extent to which brain activity during actual walking explains
mobility decline. In both cross sectional and longitudinal designs, we will determine whether poorer walking
performance and steeper trajectories of decline are associated with the Compensation Related Utilization of
Neural Circuits Hypothesis (CRUNCH). CRUNCH is a well-supported model of brain activity patterns that are
seen when older individuals perform tasks of increasing complexity. CRUNCH describes the over-recruitment
of frontoparietal brain networks that older adults exhibit in comparison to young adults, even at low levels of
task complexity. CRUNCH also describes the limited reserve resources available in the older brain. These
factors cause older adults to quickly reach a ceiling in brain resources when performing tasks of increasing
complexity. When the ceiling is reached, performance suffers. The RFA also calls for proposals to
“Operationalize and harmonize imaging protocols and techniques for quantifying dynamic gait and motor
functions”. In accordance with this call, our second aim is to characterize and harmonize high-density EEG
during walking with fNIRS (during actual and imaged walking) and fMRI (during imagined walking). This will
allow us to identify the most robust CRUNCH-related hallmarks of brain activity across neuroimaging
modalities, which will strengthen our conclusions and allow for widespread application of our findings. Our
third aim is to study the mechanisms related to CRUNCH during walking. Thus, our project will address a
majority of the objectives in NIH RFA-AG-18-019 and will identify the neural correlates of walking in older
adults, leading to unprecedented insight into mobility declines and dysfunction.

Public health relevance
Public Health Relevance: Mobility disability impacts ~30% of individuals aged 60-69, 40% of individuals aged 70-79, and 55% of individuals age 80 or older. This mobility disability accrues more than $42 billion in health care costs. Identifying the neural correlates of walking and mobility disability will guide and optimize interventions to mitigate this major health problem.